The Role of Intrinsic and Extrinsic Factors in Megakaryocytic-Erythroid Progenitor Lineage Commitment

PROJECT SUMMARY
Candidate. Dr. Scanlon, a member of an underrepresented minority, is a third year postdoctoral fellow in the
Department of Laboratory Medicine at Yale School of Medicine with degrees in Molecular Cell Biology, Diagnostic
Genetic Sciences, and Biomedical Science. She is an experimental biologist looking to expand her ability to utilize
algorithms and perform bioinformatic analyses with the long-term goal of becoming an independent investigator. Her
previous training and work with intracellular signaling pathways controlling progenitor cell response to injury combined
with her current work in hematopoiesis uniquely qualify her to conduct the proposed work. The proposed career
development plan will build upon her previous training and enhance her path toward independent research. This plan
includes experimental and didactic learning in image processing, bioinformatic analysis, algorithm optimization, and
advanced statistical analyses to independently analyze massive quantities of data. Development in these areas will
ready her for independent academic molecular and cell biology research in the current era.
Mentor/Advisors and Environment. Dr. Scanlon's primary mentor, Diane Krause, MD, PhD, and imaging
advisor, Dr. Joerg Bewersdorf, PhD will guide Dr. Scanlon through the proposed training and research activities. In addition
to Dr. Krause's extensive experience in mentoring numerous successful academic researchers, and her expertise in
hematopoietic stem and progenitor cells, and Dr. Bewersdorf expertise in high quality live imaging, Dr. Scanlon will also
receive bioinformatic analysis support and learn cell-tracking algorithms through established collaborations with Dr.
Masahiko Sato, developer of cell-tracking algorithms, and Mr. Rolando Garcia-Millian, a dedicated bioinformatic support
specialist at Yale. Dr. Scanlon will meet regularly with her mentor, advisor, and collaborators to ensure her progress. The
proposed career development plan utilizes the expertise and rich resources available at Yale to delineate additional training
activities to facilitate Dr. Scanlon's research.
Research. The molecular mechanisms underlying lineage commitment of hematopoietic stem and progenitor cells
have implications in deriving blood cells in vitro for transfusion medicine, as well as elucidating aberrant pathways
responsible for hematological disorders. Dr. Scanlon's recent postdoctoral work has focused on studying lineage
commitment of Megakaryocytic-Erythroid Progenitors (MEPs). Previous work in the lab identified MYB (a transcription
factor) to be important in controlling human MEP fate, however the mechanism remains elusive. She proposes to use live
imaging to directly visualize MEPs undergoing lineage commitment, as well as transcriptomic and epigenomic approaches
to tease apart the mechanism by which MYB regulates this process. Additionally, she will launch an independent line of
studies investigating the effect of intercellular signaling between MEP and other marrow-residing cells on MEP fate. The
results of these studies may shed light on more general rules of stem and progenitor fate decisions, as well as potentially
help derive patient-specific platelets and red blood cells for transfusions. This career development award will be an
instrumental step in Dr. Scanlon's trajectory towards an independent investigator and leader in hematopoiesis.!

Public health relevance
This application describes a mentored career development strategy for Dr. Vanessa Scanlon to obtain the necessary training to identify molecular mechanisms underlying lineage commitment of hematopoietic stem and progenitor cells. The underexplored ability of the Megakaryocytic-Erythroid Progenitor to give rise to platelet-producing megakaryocytic and erythroid lineages has the potential to fill unmet needs for safe production of blood products. Understanding Megakaryocytic-Erythroid Progenitor lineage commitment will improve the strategies to derive blood cells in vitro for transfusion medicine, as well as elucidating aberrant pathways responsible for hematological disorders. !